CK22-005, The Midwest Center of Excellence for Vector-Borne Disease

Project Summary.
This proposal details proposed activities by the Midwest Center of Excellence for Vector-Borne Diseases
(MCE-VBD) in response to the CDC Funding Opportunity RFA-CK-22-005. The MCE-VBD includes
accomplished and enthusiastic partners from academic, public health, and vector control institutions in
Wisconsin, Minnesota, Illinois, Michigan, Indiana, and Iowa. Across the region, climate change impacts on
vector-borne disease are expected as a result of 1) increased temperatures that can promote vector population
growth and affect phenological activity patterns, 2) changes in annual snow cover depth and occurrence which
impacts overwintering success of ticks and introduced mosquito species, and 3) extreme weather, with more
frequent heavy rainfall and periods of drought affecting mosquito and arbovirus outbreaks, especially in large
urban areas. The broad and long-term goal of the Center is to incentivize new and expanded interactions
between experts in the region so that responses to endemic and epidemic vector borne disease are improved
and accelerated. To achieve this goal, the project is focused on three major objectives: 1) Research to improve
prevention of human exposure to vector bites. For this aim, we will evaluate current methods of control for
mosquitoes and ticks and will develop new tools to reduce human risks of exposure. Data from research
projects will feed back into outreach and education products for use with PH, tax-funded mosquito control
districts, private pest control operators, and citizens as partners. 2) Increase the opportunities for training in
public health entomology (PHE) for students. This objective will be achieved through graduate student training
in PHE and through administration of a Certificate of PHE, with a curriculum including instruction on vector
identification, surveillance and control methods, and pesticide application licensure. We will also offer a
fellowship program which will provide paid internships in PHE and have established partnerships to enhance
recruitment of students from underrepresented backgrounds. 3) Build a community of practice including public
health and mosquito control experts at the county and district/municipal level, state public health experts,
professional pest control companies, and academic scientists at research institutions. This goal will be
achieved by evaluating region-specific public health educational efforts and interacting to establish best
practices for VBD management. Successful completion of these objectives will dramatically expand the
ability of public health authorities in the Midwest to detect and respond to threats as well as provide a
strongly supported evidence-based practice for management of vector-borne disease.

Public health relevance
Project Narrative. This project addresses issues of critical importance to management of vector-borne disease (VBD) in the United States, including those caused by viruses transmitted by mosquitoes (West Nile) as well as tick-borne pathogens like Borrelia burgdorferi (Lyme Disease). Because the upper Midwest is a national hotspot for Lyme Disease and other tick-borne diseases and is notable for endemic transmission and periodic epidemics of West Nile and Eastern Equine Encephalitis viral diseases, we believe the Midwest Center of Excellence for Vector-borne Disease (MCE-VBD) is ideally positioned to address these challenges. The Center is a truly regional organization covering Wisconsin, Minnesota, Illinois, Michigan, Indiana, and Iowa. Center activities will focus the efforts of a formidable group of nationally recognized public health entomologists, epidemiologists, public health experts, and public and private vector control leaders to improve prevention and control practices. The goals include testing and improving existing methods of mosquito and tick management and bite prevention, evaluating new products and methods, supporting the training of the next generation of medical/public health entomologists, and enhancing a strong community of practice. Our efforts will engage academics, public health partners, public vector control agencies, and private pest control operators. Results and conclusions will be directly relevant to both the major VBD issues of the region as well as broadly applicable to public health entomology in the United States.